REPOSITORY SERVICES FOR BRAZILLIAN HPTN SPECIMENS FOR THE MPIDB

The NICHD conducts studies focusing on child health and human development and as such has generated and will continue to generate a collection of human biospecimens pertaining to these research activities